Human gene transfer & macrophage cell transplantation therapy of hereditary PAP (hPAP)

ABSTRACT
Gene complementation and pulmonary macrophage transplantation (PMT Therapy) is a promising potential
therapy of hereditary pulmonary alveolar proteinosis (hPAP) – a disorder of progressive of alveolar surfactant
accumulation and respiratory failure – for which no pharmacotherapy therapy exists. We defined the patho-
genesis, presentation, diagnosis, and management of hPAP, showed it is caused by the loss of GM-CSF re-
ceptor signaling and disruption of alveolar macrophage (AM) functions including the removal of surfactant from
alveoli. We demonstrated lentiviral vector-mediated complementation of function-disrupting CSF2RA mutations
restored GM-CSF receptor signaling in human AMs including rescue of surfactant clearance. Despite outstand-
ing progress, including demonstration of the safety, tolerability, efficacy, and durability of PMT Therapy in two
validated hPAP animal models, lack of clinical studies of PMT Therapy in humans is a critical barrier to its fur-
ther therapeutic development. Our long-term goal is to develop PMT Therapy as the an effective, disease-
specific therapy of hPAP (and possibly other diseases). The objective here is to complete preparations for, and
then to conduct, a Phase I trial to establish the safety of PMT in human patients with hPAP and also identify
useful clinical and biological outcome measures informing the design of a future Phase II efficacy trial.
The central Hypothesis is that after PMT of autologous CD34+ cell-derived CSF2RA gene-corrected macro-
phages without myeloablation, the transplanted cells will survive, engraft, adopt the phenotype and function of
normal AMs, replace endogenous AMs, reestablish a normal-sized AM population that remains in the lungs
and results in a safe, well-tolerated, effective, and durable treatment benefit. The rationale for the proposed
research is that a ‘first-in-human’ study establishing the safety of PMT Therapy in humans will unblock further
clinical development of PMT Therapy including preparation for conduct of a future phase 2 clinical efficacy trial.
We plan to address our hypothesis by pursuing four specific aims in the R61 phase and three aims in the R33
phase: 1) finalize stability testing of CSF2RA gene-corrected macrophages; complete 2) trial-related and 3)
IND-related documents; 4) obtain regulatory approvals (Institutional Review Board and Biosafety Committee,
Data, Safety, and Monitoring Board, FDA); 5) assess the safety, 6) measure the pharmacokinetics and phar-
macodynamics, and 7) identify useful measures of the clinical outcomes and biological signature of PMT Ther-
apy in hPAP patients. The proposed research is innovative because it represents a marked departure from the
current treatment approach, whole lung lavage (an invasive, inefficient, procedure to physically remove surfac-
tant) by establishing, in hPAP patients, the feasibility of a new approach to restore a GM-CSF-responsive,
functional AM population. The proposed research is significant because establishing the safety, pharmacoki-
netics and pharmacodynamics, and identifying useful clinical outcome measures of PMT Therapy in humans is
the next step in our clinical research program to develop PMT as the first specific therapy of hPAP.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it is expected to establish the feasibility of the first specific therapy for hPAP in children and introduces a novel approach for treating lung diseases, pulmonary macrophage transplantation. This approach will represent a major improvement over the current therapy, whole lung lavage, which is inefficient, highly invasive, and unavailable at most clinical centers particularly for use in children, some of whom require it as frequently as every one to two months. Thus, the proposed re- search is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burden of human illness, and will also inform mechanisms by which GM-CSF contributes to alve- olar macrophage development, surfactant homeostasis, and lung function in health and disease.